Hypofractionated radiation in combination with B7-H3-CAR T cells for pediatric patients with relapsed/refractory sarcomas

PROJECT SUMMARY/ABSTRACT
My overarching career goal as a clinician scientist is to become an independent investigator, who develops novel
cellular immune therapies to improve outcomes for pediatric patients with high-risk malignancies. This K08
application proposes a career development plan and research strategy that are structured to provide the focused
mentorship, dedicated coursework, hands-on training, and protected time that will be necessary for me to
successfully transition into an independent leadership role. My research plan addresses the unmet need that
pediatric patients with relapsed/refractory (r/r) sarcomas have dismal outcomes with current approaches, and
initial attempts to translate cellular immunotherapy for this population have been limited by the hostile tumor
microenvironment. My proposal centers on the hypothesis that priming with hypofractionated radiation
therapy (HFRT) will modulate the local and systemic tumor environment, improving the antitumor activity
of B7-H3-CAR T cells. To interrogate this hypothesis, I will implement a phase I clinical trial evaluating the safety
and antitumor activity of B7-H3-CAR T cells post HFRT and lymphodepleting chemotherapy in pediatric patients
with r/r sarcomas (Aim 1). I will oversee the conduct and interpretation of embedded correlative studies, together
with laboratory-based collaborators, seeking to assess the in vivo expansion, persistence, and functional state
of B7-H3-CAR T cells and elucidate mechanisms of immune escape (Aim 2). Importantly, while these aims focus
on pediatric patients with r/r sarcomas, B7-H3-targeted therapy has the potential for application in a range of
pediatric and adult malignancies. The proposed correlative studies will produce generalizable knowledge about
the interaction between radiation and the immune environment informing broad combination immune therapy
efforts. I have developed a scholarly oversight committee composed of senior investigators who are
leaders in their respective disciplines, possess diverse technical expertise, and have track records of
successful research, mentorship, and funding support. Together with my mentors and advisors, I have
crafted a career development plan focused on the goals of i) gaining an oncology perspective in multimodal
treatment strategies for pediatric solid tumors, ii) applying advanced techniques in biostatistics and early-phase
clinical trial design, iii) designing and interpreting robust immunologic correlative studies, and iv) cultivating
leadership skills. The rigorous training provided by this mentored award will prepare me for a career dedicated
to translating novel cellular immune therapies for pediatric patients with high-risk malignancies through early-
phase clinical trials and integrated correlative studies to enable reverse translation. Upon completion of the K08
award period, I expect to have garnered the necessary training to support my transition to an independent
investigator role and generated data that will inform subsequent clinical trial R01 applications supporting future
combination cellular therapy efforts for pediatric solid tumors.

Public health relevance
PROJECT NARRATIVE Pediatric patients with relapsed/refractory sarcomas have poor outcomes despite aggressive attempts at multimodal therapy. Chimeric antigen receptor (CAR) T cell therapy offers an alternative strategy by redirecting the patient’s immune system towards the tumor, but initial attempts to translate this approach for solid tumors have been limited by the hostile tumor microenvironment. In this proposal, I aim to improve the antitumor activity of B7-H3-CAR T cells through combination with hypofractionated radiation therapy to produce local and systemic immunomodulatory effects.